Identification of diffusible small molecules that regulate replication of Porphyromonas gingivalis

Project Summary
Porphyromonas gingivalis (Pg) is a late-colonizer with a demonstrated role in the etiology of periodontitis and
implicated as a risk factor in several systemic conditions. Our previous work showed that population size, which
determines the availability of a still unidentified endogenous diffusible small molecule(s), limits the in vitro growth
and the in vivo colonization and virulence of Pg. Our work also showed that the inability of Pg to grow in vitro
and colonize in vivo from a small inoculum was overcome by forming a partnership with the ubiquitous Gram-
negative early colonizer Veillonella parvula (Vp). In preliminary studies we show that intermediates of
menaquinone biosynthesis may play a role stimulating growth of low cell-density Pg and may be produced by
certain strains of Pg and by Vp. However, other strains of Pg capable of supporting their own growth via small
diffusible cues present in their spent media may utilize a different strategy as they do not have the machinery for
menaquinone biosynthesis. Accordingly, the overall goal of this application is to establish the identity of the
growth-promoting cues produced by different strains of Pg and by Vp that support Pg replication from a low cell
density population. Therefore, in this proposal we will utilize chemical and molecular genetic strategies to identify
the soluble cues produced by Pg 381, Pg W83 and Vp that stimulate growth of Pg from low cell density inocula.
We anticipate this work will elucidate the mechanisms regulating cell density-dependent replication in different
strains of Pg and the manner in which inter-species interactions with early biofilm colonizers, such as Vp, can
help Pg overcome the growth barrier and allow its replication and establishment in the oral cavity.

Public health relevance
Project Narrative Despite the essential role of Porphyromonas gingivalis (Pg) in oral and systemic health, little is known about the factors that allow its colonization of the oral cavity. This project will identify small molecules produced by this pathogen or by the commensal Veillonella parvula that modulate growth of Pg from a low cell density population. This knowledge may lead to preventive strategies to control the oral establishment and subsequent systemic spread of Pg.